Structural Virology of Tripartite Motif Proteins

PROJECT SUMMARY
Tripartite motif (TRIM) proteins are ubiquitin E3 ligases that function in development and innate immunity. TRIM5a and
TRIMCyp proteins (collectively termed TRIM5) recognize and deactivate the incoming cores of retroviruses such as HIV-
1. Indeed, human TRIM5a is an important component of interferon-mediated control of HIV-1 infection. Previous work
from our group suggested an unprecedented lattice-to-lattice mode of pattern recognition, in which TRIM5a dimers use
the viral capsid surrounding the viral core as a template for higher-order assembly, ultimately forming a cage around the
core. In the current funding period of this R01 project, we solved the first structure of the TRIM5a/capsid superlattice,
developed and optimized a recombinant assembly and ubiquitination system for TRIM5/capsid complexes, and
collaborated in studies that reconstituted the early events of HIV-1 replication in a cell-free system. In this renewal
application, we now propose to: Aim 1, extend the resolution of our TRIM5a/capsid superlattice structure, in order to
visualize contacts between the arrayed TRIM5a protein dimers and their bound viral CA protein hexamer subunits. Aim
2, utilize our novel in vitro ubiquitination and HIV-1 replication systems as experimental platforms to elucidate how
TRIM5 deactivates its caged viral core. Aim 3, understand a novel mechanism of TRIM5 recognition, in which the
homologous TRIM34 protein directs human TRIM5a to bind and inactive HIV-1 capsids bearing the N74D mutation.
Collectively, these studies will fill in important missing gaps in our understanding of how TRIM5 proteins inhibit HIV-1
replication. Our developing understanding of TRIM5 has been giving important insights on HIV-1 capsid vulnerabilities
and efforts to develop drugs that exploit these vulnerabilities.

Public health relevance
PROJECT NARRATIVE TRIM5 proteins constitute a powerful innate cellular defense machinery against important human pathogens such as HIV- 1 and other retroviruses. The continuing goal of this R01 project is to understand the detailed molecular mechanisms by which TRIM5 recognizes and inhibits HIV-1. Our studies on this naturally-evolved antiviral enriches understanding of the fundamental mechanisms of HIV-1 replication, and also identifies viral vulnerabilities that can be exploited to fight HIV/AIDS.